IPMK is a novel PI3k essential for mTORC2 activation and cell migration

PROJECT SUMMARY
IPMK is a novel PI3K crucial for AKT activation and cell migration. Our previous research demonstrated that the
loss of IPMK's PI3K activity impairs PDK1's membrane localization, disrupting PDK1-mediated AKT
phosphorylation. To achieve complete AKT activation, phosphorylation by mTORC2 is essential. Interestingly,
mTORC2 activation relies on PIP3. The essential PI3K responsible for generating PIP3 required for mTORC2
activation remains unidentified. Our investigation is focused on understanding the mechanism behind the
activation of mTORC2 by PI3K IPMK. We aim to decipher the impact of IPMK's PI3K activity on mTORC2
activation. We will also explore whether IPMK's PI3K activity affects cell migration by activating mTORC2 or
through an independent pathway. Furthermore, we will delve into how IPMK's PI3K activity influences the
organization of the actin cytoskeleton, a critical element in the process of cell migration. The following aims will
be explored to investigate the hypothesis: “IPMK is a novel PI3k essential for mTORC2 activation and cell
migration.” Specific Aim 1: Mechanism of IPMK-Mediated mTORC2 Activation. In this aim, we will elucidate
the molecular mechanism underlying IPMK-mediated mTORC2 activation. Specific Aim 2: Impact of
Phosphorylation on IPMK's PI3k Activity. We will identify the specific phosphorylation sites in IPMK necessary
for its PI3K activity and investigate how phosphorylation-deficient mutants of IPMK affect downstream functions
such as AKT activation, mTORC2 activation, and cell migration. Specific Aim 3: Regulation of Cell Migration
by IPMK and its PI3K Activity. This aim will assess how IPMK and its PI3K activity influence actin
polymerization, a crucial factor in cell migration. Mechanistically, we will determine whether IPMK-mediated cell
migration relies on mTORC2 or operates independently. By addressing these specific aims, we aim to shed light
on the intricate roles of IPMK's PI3K activity in mTORC2 activation and cell migration, contributing to our
understanding of this novel pathway and its potential implications.

Public health relevance
Project narrative: IPMK is a novel PI3K that is necessary and sufficient for mTORC2 activation in specific cellular compartments, maintaining actin cytoskeletal dynamics and cell migration. Aberrant mTORC2 activation and cell migration are linked to various diseases. Understanding the mechanism of IPMK-mediated mTORC2 activation and cell migration will be useful in understanding disease mechanisms and fundamental cell biological processes.